Neurogenetic Investigations of Obsessive-Compulsive Disorder

Obsessive-compulsive disorder (OCD) is a disabling early-onset neuropsychiatric disorder with unclear
underlying pathophysiology, which has hindered the development of new treatments and interventions. While
there is a clear genetic contribution to OCD risk, decades of investigations have yet to yield reproducible,
statistically significant findings that have identified high-confidence risk genes. Progress in leveraging genetics
to clarify biology has likely been impeded by multiple factors, including a narrow focus on common genetic
variants with small effect sizes, underpowered study designs, general uncertainty about the spectrum of
genetic variation that should be queried, and limited attention to downstream gene expression and associated
epigenetic signatures that drive gene expression in relevant tissue. There is a critical need for further efforts
using alternate approaches to identify and confirm risk genes that will provide insights into OCD biology. The
overall objective of the current proposal is to use high-throughput sequencing approaches to identify OCD risk
genes, detect gene expression differences in OCD, and determine epigenetic signatures driving gene
expression in OCD brain. This will be accomplished by pursuing three specific aims. Aim 1 proposes to (a)
identify high-confidence risk genes by whole-exome sequencing and de novo genetic variant detection in 500
OCD parent-child trios and 500 control trios; (b) replicate these analyses with collaborator data from 475 OCD
trios and 1,000 OCD probands; and (c) integrate OCD risk genes into systems analyses to identify enriched
gene networks, pathways, and spatiotemporal expression patterns. Aim 2 proposes to identify somatic mosaic
variants in exome sequencing data from all OCD and control trios, and from peripheral blood and brain tissue
from 10 OCD subjects. Aim 3 proposes identification of differentially expressed genes and chromatin
signatures in brain tissue from 10 OCD and 10 matched control subjects using RNA-seq, ChIP-seq, and
ATAC-seq. The proposed research attempts to close gaps in our knowledge of OCD biology by a series of
studies that specifically addresses Objective 1 of the NIMH Strategic Plan (defining the mechanisms of
complex behaviors). If successful, this research will transform our understanding of the underlying mechanisms
of OCD and identify points of traction for mechanistic studies in model systems, ultimately leading to novel
therapeutics, and reducing the significant morbidity and mortality associated with this disabling illness.
Furthermore, insights gained in these studies can inform gene discovery approaches to other complex
neuropsychiatric disorders.

Public health relevance
This work will address important gaps in the knowledge base regarding genetic risk factors, developmental time course, and neurobiological basis of obsessive-compulsive disorder (OCD), a disabling early-onset neuropsychiatric disorder with a lifetime prevalence of 1.5-2.5%. Findings from this research will transform our understanding of the underlying mechanisms of OCD, identify targets for novel treatments, and ultimately contribute toward reducing the significant morbidity and mortality associated with this disabling illness.